RIG-I-like receptor regulation of pulmonary inflammation and homeostasis

PROJECT SUMMARY
Stringent regulation of inflammation during infectious and non-infectious diseases is critical for limiting tissue
pathology while promoting disease resolution. The dead-box helicase family members known as retinoic acid-
inducible gene I-like receptors (RIG-I-like receptors, RLRs) play a critical role in recognizing self and non-self
nucleic acids in the cytosol of host cells. Dysregulation of RLRs and their downstream interferon (IFN) and
inflammatory signaling cascade can manifest as autoimmunity or as defects in antimicrobial responses. Despite
the critical importance of RLRs, the function of these receptors and their associated molecular pathways in
different cell types, remains an important gap in our understanding of tissue homeostasis versus diseased states.
As an independent investigator, my studies now focus on how emerging non-canonical functions of RLRs and
IFN regulate inflammation in the context of pulmonary pathogenesis and immune cell programming, two critical
areas in which better understanding of RLR-associated signaling could lead to new strategies for treating
infectious and non-infectious inflammatory diseases. Our preliminary studies have found that atypical induction
of the RLR RIG-I using a synthetic agonist leads to activation of immune cell programming genes rather than
IFN induction. Moreover, we have identified new roles for type III IFN (IFN) in pulmonary tissue repair following
pathogen-induced damage. My research program can be defined with three thematic goals: 1) elucidate how
RLRs and IFN pathways contribute to tissue homeostasis, 2) determine whether RLR and IFN pathways are
differentially activated in a strategically-selected set of cell types in damaged vs adjacent tissues, and 3)
determine the distinct contributions of RLR and IFN in controlling non-infectious or infection-mediated
inflammation and resolution. We have developed first-of-their-kind mouse models to eliminate expression of the
RLRs RIG-I, MDA5, and their downstream signaling adapter MAVS, as well as type I and type III IFN signaling
pathways in temporal and cell-specific fashions. These tools will allow us to use cutting edge high-parameter
spectral cytometry, along with spatial transcriptomics, to define the most relevant inflammatory pathways
deployed by individual cell types in the context of their natural tissue microenvironment. Ultimately, our studies
will improve understanding of cell-intrinsic regulation of nucleic acid sensing pathways, and will provide strategies
for differentially targeting each pathway to maximize therapeutic benefit while minimizing adverse side effects.

Public health relevance
PROJECT NARRATIVE Sensing and discrimination of foreign vs host nucleic acids is key for providing protection against pathogens while preventing autoimmunity. The nucleic acid sensors known as retinoic acid inducible gene I (RIG-I)-like receptors (RLRs) are critical to regulating pulmonary inflammation, protection from damage, and repair, but the roles for RLRs in discrete cell types and tissue microenvironments remains unknown. This R35 research program will utilize novel RLR (RIG-I and MDA5) genetic knockout murine lines to unravel the unique roles of the RLRs in regulating pulmonary homeostasis, pathology, and tissue repair.